Primary Prevention of Stroke in Children with Sickle Cell Anaemia in Nigeria: Community vs Teaching Hospital

ABSTRACT
Stroke is a frequent complication of sickle cell anemia (SCA) that is associated with increased morbidity
and mortality. Without any intervention, ~11% of children with SCA will develop stroke before their 17th
birthday. Evidence-based practices for primary stroke prevention include screening for abnormal
transcranial Doppler (TCD) measurements coupled with regular blood transfusion therapy for at least one
year, then hydroxyurea therapy for an indefinite period. In high-resource countries this strategy has
dropped stroke incidence rates by 92%. In Nigeria, approximately 150,000 children with SCA are born
annually, accounting for more than half of the total births with SCA worldwide. In comparison, there are only
1,700 affected births of children with SCA in the United States annually. Among each birth cohort, 15,000
children will have stroke annually in Nigeria. In 2016, as part of the capacity building objective of our Stroke
Prevention Trial in Nigeria (SPRING,1R01NS094041) at Barau Dikko Teaching Hospital (BDTH) in Kaduna,
TCD screening was adopted as standard of care. Before the trial, no TCD screening was performed at our
trial site. Currently as standard of care, physicians at BDTH perform TCD screening, however, only 5.4%
(1,101/20,040) of the eligible children with SCA living in Kaduna, Nigeria were reached. With just 21
radiologists and only 3 certified in TCD screening in Kaduna State, clearly, to achieve a decrease in stroke
incidence among children with SCA living in Kaduna, and elsewhere, we must have a better
implementation strategy to increase TCD screening. We therefore propose to initiate a stroke prevention
program in a community hospital in Kaduna, Nigeria by task-shifting TCD screening and stroke detection to
nurses. The aims of this proposal are to: 1) Identify barriers and facilitators that influence the adaptability of
the transported intervention, including implementation process; 2) Build capacity for stroke detection and
prevention in SCA in a community hospital; and 3) Conduct a feasibility trial comparing the effectiveness of
a physician-based primary stroke prevention program in a teaching hospital to a task-shifted primary stroke
prevention program in a community hospital.The proposed training and research will be conducted at Barau
Dikko Teaching Hospital and Yusuf Dantsoho Memorial hospital in Kaduna, Nigeria and will provide
preliminary data for a definitive randomized clinical trial in implementation science. A mentoring team of
senior researchers in United States and Nigeria will supervise the applicant. The mentoring team has
extensive research expertise in clinical trials in sickle cell disease and implementation science. The overall
research objective is to develop strategies that will improve primary prevention of strokes in children with
SCA.

Public health relevance
Project Narrative Stroke is a devastating complication of sickle cell anemia (SCA) still occurring in approximately 11% of children affected with the disease in resource-limited countries, compared to 1% in high-income countries. In Nigeria, the country with more than 50% of the global burden of SCA, screening for at risk children using transcranial Doppler ultrasound (TCD) measurements is limited to tertiary hospitals. This mentored award is focused on initiating a stroke prevention program in a resource-limited community hospital by task shifting of TCD screening to nurses, a strategy that is expected to increase access for affected children with prompt institution of a primary prevention strategy for those with increased stroke risk.